Statistical methods for gene regulatory analysis of substance use disorder

Project Summary
Substance use disorder (SUD) presents a pressing global health issue with devastating consequences, including
physical and mental health risks, as well as substantial economic burdens. Despite extensive research efforts,
the lack of efficient therapies underscores the critical need for a more comprehensive system-level
understanding of the underlying mechanisms driving addiction. SUD is a complex trait influenced by genotypes,
cellular environments, and drug exposure. However, existing studies often focus on only one or two of these
factors, leading to a limited understanding of the full picture.
We propose to leverage GRNs as an integrative framework that bridges genotypes, cellular environments, and
drug exposure, enabling a more holistic and system-level comprehension of addiction mechanisms. The
objective of this research project is to develop cutting-edge statistical methods and bioinformatics tools that will
enable a systems-level analysis of SUD. By integrating diverse data types, such as genome-wide association
studies (GWAS) and single-cell multiome data from both Drosophila and human brain samples of addicted
individuals and controls, we aim to identify crucial genotype-affected addiction-causing cells (“affected cells”),
driver regulators, and gene regulatory networks (GRNs) associated with SUD.
Aim 1 of the research will focus on developing a novel method to identify "affected cells" that serve as a link
between genotypes and SUD. Leveraging data from GWAS, we will compare the expression of SUD-associated
genes in addicted individuals and controls, allowing us to pinpoint cellular populations affected by addiction-
related genetic variations. This integrative approach will shed light on the cellular mechanisms that contribute to
addiction susceptibility. In Aim 2, we will advance state-of-the-art methods to elucidate the causal reasons behind
differentially expressed genes observed in addicted individuals compared to controls. By investigating the role
of driver regulators responsible for addiction, we will identify key GRNs governing addictive behaviors. This
integrated analysis will provide a comprehensive view of the regulatory landscape underlying SUD.
The outcomes of this project are poised to advance understanding of addiction mechanism significantly.
Successful implementation will result in the development of broadly applicable novel methodologies, offering a
new perspective on understanding complex traits, including SUD, from a systems biology viewpoint. Specifically,
we aim to unravel how driver regulators respond to substances and influence genes and chromatin through
GRNs, gradually leading to addiction. This enhanced system-level understanding of addiction biology will have
far-reaching implications, paving the way for the development of new therapeutics aimed at modulating or
reversing the transcriptional or regulatory actions contributing to SUD.

Public health relevance
Health Relevance Statement The goal of this research is to develop new statistical methods for the comprehensive analysis of Substance Use Disorder (SUD). By integrating diverse data types from human and model organism samples, these methods aim to identify affected cells, driver regulators, and gene regulatory networks associated with SUD, thereby advancing our understanding of addiction at a systems level and contributing to future efforts in addiction prevention and treatment. The relevance of this research lies in addressing SUD as a critical global health issue with significant risks to physical and mental well-being, as well as economic burdens.